Scalable tools to effectively translate genomic discoveries into the clinic

PROJECT SUMMARY
We are in the midst of a genomic revolution; more than 250,000 human genomes have been sequenced,
generating over a petabase of genomic data. While these new data hold great promise to impact health, there
is a disconnect between genomic discovery and clinical care. Providers frequently misinterpret genomic
information, patients often don't understand their own test results, and genomic information about disease risk
is infrequently shared between patients and family members. Importantly, ineffective communication and data
misinterpretation has devastating consequences- including unnecessary organ removal, missed disease
prevention opportunities, and premature death.
We are addressing these genomic care gaps by developing and testing tools that optimize the integration of
whole-exome and whole-genome sequencing (WES, WGS) for general clinical practice. My vision for
improving genomic medicine is based on my work within multidisciplinary consortia and addresses the National
Human Genome Research Institute's priority research area of improving the effectiveness of healthcare. In the
proposed work we will test the effectiveness of a multilevel genomic e-Health intervention in cancer (Aim 1).
Our intervention 1) educates physicians and patients about genomics, 2) enables direct-to-patient return-of-
results, 3) provides physicians with patient-specific results and resources for interpretation, and 4) facilitates
sharing of genomic results within families. We hypothesize that intervention use will result in higher rates of
uptake of high-quality, genetically guided care. We will test our hypothesis in a randomized controlled trial
among academic and community physicians who use WES for their patients. Next, we will use an iterative
process, with stakeholder engagement, to adapt and pilot test our tool for Spanish and Mandarin speaking
patients and for patients who have diabetes (Aim 2). Finally, we will create and assess new, moderated, social
networks as a platform for genomic information sharing (Aim 3). Our hypothesis is that providers, patients and
family members will engage with the genomic information sharing social networks and find them to be highly
useful. Our general approach includes 1) creating the secure social networks, 2) integrating the networks into
our e-Health intervention, and 3) using complementary methods, such as interviews and natural language
processing, to assess stakeholders' network-related attitudes and network information quality. If successful, we
will be well positioned to widely disseminate our e-Health tools. In sum, this work stands to transform how
people obtain, process and share genomic information in the context of clinical care. Our tools reconceive
genetic communication to allow for multi-directional flow of information, connects multiple stakeholders with
one another, and integrates high-quality dynamic web-based resources to improve genomic care. In creating
and deploying tools that both respond to and leverage the complexities of our information environment, we
intend to transform genomic research and clinical practice.

Public health relevance
PROJECT NARRATIVE/ RELEVANCE OF PROJECT TO RESEARCH AND PUBLIC HEALTH Widespread utilization of genomic sequencing in medicine creates an urgent need to educate providers and patients. Currently, providers frequently misinterpret genomic information and patients often don't understand their own test results. In order to address this critical need, we propose to design and test multiple e-Health communication tools that will help providers and patients to better understand genomic data, lead to higher quality patient care, and facilitate genomic information sharing within families.